Shared Resource Management (SRM)

PROJECT SUMMARY – SHARED RESOURCE MANAGEMENT
The Salk Cancer Center (SCC) Shared Resources (SR) are dedicated research laboratories within the Salk
Institute that provide centralized access to instrumentation and services to meet the continuing research needs
of the SCC labs. They each occupy a shared-space environment that promotes interactions and collaborations
and are designed with a framework that allows expansion and evolution to stay at the cutting edge of technology
and meet the future needs of SCC researchers. Strong scientific and technical leadership is provided by the SR
directors and staff, who are readily available for high-level consultation and training for optimal experimental
design, data acquisition and interpretation to accelerate and optimize scientific discovery by SCC investigators.
CCSG funds are requested to continue to support the following shared resources: Advanced Biophotonics
(BPHO), Flow Cytometry (FCC), Integrative Genomics and Bioinformatics (IGC), Mass Spectrometry (MASS),
Next Generation Sequencing (NGS), Transgenics (TGC), and Viral Vector (VVC)
The SR are managed by the Shared Resource Management Group (SRMG) appointed within the last year.
The SCC Deputy Director for Shared Resources (DD SR), Gerald ShadelGEA (appointed in June 2022) capably
leads this team, which provides effective oversight to the SRs. ShadelGEA is also the current (until 2024) Chair
of the Salk Institute Core & Infrastructure Committee (C&IC), an appointed faculty governance committee. This
provides critical SCC representation (the DD SR position is now a permanent, non-voting ex officio member) and
leadership (voting rights as Chair) on this institutional committee. The SMRG are also members of the SCC
Executive Leadership team, which ensures transparency regarding operations.
Over the current funding period, the $4.2M budgeted funding for the SR from the CCSG was augmented by
$7.0M in Salk institutional operating support with strong return on investment as documented by usage metrics
and publications. In addition, during the same period, technologies that were added to the SR portfolio include a
Vizgen MerScope, Illumina sequencers, spatial transcriptomics technologies (IsoPlexis, NanoString GeoMx
DSP). In addition, through a partnership with Scripps Research, Salk invested in access to cryo-EM technology.
To support data management, investments in data storage and computation were also made. The capital
equipment investments over the past five years, funded largely by the Institute, represent an ~$8.5M investment.
In the current funding period, the CCSG annual budget contribution supporting the Shared Resources is $821K,
which is 18% of the annual average SR operating budget of $4.7M. The other 82% is provided by the institution,
other grants, and recharge funds. SCC requests $899,116 in annual support for the seven CCSG-funded Shared
Resources and Shared Resource Management personnel for the next funding period, which continue to be
leveraged by Institutional funds of $1.64M annually (25% of total operating expense).